A novel cellular tumor vaccine strategy for mutant IDH1 glioma

ABSTRACT – Project 3
The progression of primary brain tumors in children from low grade (LGGs) to lethal high grade gliomas
(HGGs) typically occurs over a 10 year period and is not prevented by traditional therapies. Although
immunotherapy seems to be an ideal alternative therapeutic approach for LGG tumors due to the ample time
window between resection and recurrence during which anti-tumor immunity can be stimulated, attempts to
develop the approach have been unsuccessful. The most common mutation found in LGGs, IDHR132H, is
located in the isocitrate dehydrogenase 1 (IDH1) gene and is ubiquitously expressed in all tumor cells.
Unfortunately, although its prevalence and ubiquity make IDHR132H an excellent tumor vaccine target, it has
proven to be very poorly immunogenic, especially in generating CTL responses. This Project aims to overcome
this hurdle by establishing proof of principle for a novel monocyte vaccination strategy for IDHR132H+ gliomas.
The approach exploits an endogenous antigen (Ag) cross-presentation presentation pathway that uses
resident splenic dendritic cells (DC) to significantly improve the survival of mice bearing intracranial IDH1R132H+
CT2A tumors. Our preliminary data suggest that this strategy may stimulate anti-IDH1R132H CD8+ T cell
responses. Building on these findings and additional preliminary data showing that Flt3L markedly improves
monocyte vaccine efficacy in mouse models of melanoma, the Project will test the hypotheses that monocyte
vaccination can induce effective anti-IDH1R132H CTL responses in mice, that these responses can be increased
by Flt3L administration, and that monocyte vaccination will safely stimulate robust anti-IDH1R132H immune
responses in humans. The objectives of this project are to determine the specific mechanisms by which
monocyte vaccination inhibits IDH1R132H glioma growth (Aim 1), to determine if Flt3L improves the efficacy of
monocyte vaccination for IDH1R132H-expressing gliomas in mice (Aim 2), and to determine if IDH1R132H
monocyte vaccination is safe and immunogenic in humans (Aim 3). These studies are expected to provide
proof of principle that an entirely novel vaccine strategy, monocyte vaccination, possibly in combination with
Flt3L administration, provides superior efficacy to alternative strategies in animal models of IDH1R132H gliomas,
determine the mechanisms by which this efficacy is achieved, and demonstrate that this strategy is safe and
immunogenic in a relevant patient population. If successful, this Project will provide the rationale and critical
information needed for future studies of monocyte vaccination, which has the potential to significantly improve
outcomes in patients with IDH1R132H-expressing gliomas.

Public health relevance
PROJECT NARRATIVE – Project 3 Primary brain tumors are the most frequent cause of cancer death in children and young adults. Brain tumors typically begin as slow growing low grade gliomas (LGGs) that transform in almost all cases to a universally lethal high grade glioma (HGGs) within 10 years. Traditional therapies do not prevent the ultimate progression from LGG to HGG. This project proposes a cell-based vaccine strategy to target a mutation in isocitrate dehydrogenase 1 (IDH1) found in the vast majority of LGGs and secondary HGGs. This vaccine strategy has the potential to significantly improve outcomes in patients with mutant IDH1-expressing gliomas.